Novel doula intervention to leverage clinic-community connections to support perinatal intimate partner violence survivors

ABSTRACT
Intimate partner violence (IPV) during the perinatal period is a pervasive and devastating public health epidemic.
IPV also intersects with structural and institutional violence, particularly for Black, Latine, low income, and sexual
and gender diverse (SGD) people, who report experiencing systems-level violence during the perinatal period.
Healthcare settings offer a unique opportunity to support perinatal IPV survivors and connect them with
community-based resources, as they come for regularly scheduled prenatal and postpartum visits. Universal
empowerment is a promising healthcare-based IPV intervention, where IPV related education and resources are
provided to all perinatal patients, avoiding some of the challenges of the traditional screen and refer approach.
Universal empowerment has been tested and shown to be effective and feasible in other settings such as family
planning clinics and school-based health centers, but has not been rigorously evaluated during prenatal visits.
Universal empowerment may be further optimized by doula-based support for IPV survivors, as doulas have
been shown to improve other health outcomes (e.g., preterm birth, access to perinatal visits) although less is
known about their effect on reducing IPV. Doulas may be particularly effective in buffering perinatal people from
discrimination and bias experienced in healthcare and social services systems, which is critical for IPV survivors
with marginalized or multiply marginalized identities who experience both IPV and structural violence. In
response to RFA-NR-23-004, the objective of this application is to conduct a 2-arm type 1 hybrid trial with 250
perinatal people (125 per group) to test the effectiveness of an enhanced universal empowerment intervention
delivered during 28–32 week prenatal visits (Thrive) compared with universal empowerment plus pairing with an
IPV-trained doula (Doula Thrive). In Aim 1, we will assess the effectiveness of both Thrive and Doula Thrive in
reducing IPV (primary outcome; defined as a range of coercive and controlling behaviors), as well as perinatal
cannabis use, tobacco use, and depression (secondary outcomes). We hypothesize that while both interventions
will reduce IPV, we will find a greater effect for Doula Thrive. In Aim 2, we will conduct mediation and moderation
analyses to test mechanisms through which the intervention is effective and to elucidate survivor profiles
moderating intervention effectiveness. Through interviews, surveys, and tracking data, in Aim 3 we will collect
data on implementation factors aligned with the PRISM framework. We have convened a community-academic
team with expertise in IPV, perinatal disparities, doula care, community-partnered research, clinical trial design
and analysis, and implementation science; IPV survivors will be core partners in this work. Results will inform
the design of a future implementation trial to test further implementation, dissemination, and sustainability. This
intervention has the potential to be transformative in supporting perinatal IPV survivors through community-clinic
linkages, ultimately reducing IPV-related disparities and promoting health equity.

Public health relevance
NARRATIVE Intimate partner violence (IPV) is common and particularly dangerous during the perinatal period. Healthcare- community linkages, particularly through use of community-based doulas, offer an important opportunity to support perinatal survivors and ultimately reduce IPV and improve health outcomes. Through a community- academic partnership, this study will evaluate the effectiveness of a healthcare based universal empowerment intervention delivered during prenatal visits compared with universal empowerment plus an IPV-trained doula in reducing perinatal IPV.